Assessing the links between risk factors, COVID-19 impacts, and reading skills

PROJECT SUMMARY
The COVID-19 pandemic has presented a sudden yet persisting set of stressors for children across the
U.S., that have had far-reaching impacts on their wellbeing, health, and academic outcomes. The COVID-19
pandemic brought about an unprecedented number of school closures that have impacted learning for nearly
78 million children (UNESCO, 2021). Learning to read is crucial, as reading is a critical indicator of lifetime
earnings, general health, and wellbeing (OECD, 2012). Before the pandemic, many children were already at
risk for reading difficulties, with only 35% of U.S. fourth graders showing proficient levels of reading
ability (NCES, 2019). These reading difficulties have only been magnified by COVID-19 related
impacts. Data from the 2020-2021 school year shows that children’s reading scores got worse, with average
end of year reading scores 3 to 6 percentile points lower than pre-pandemic levels (Lewis et al., 2021). The
overall goal of this project is to uncover the mechanisms through which COVID-19 has and will have short-term
and long-term impacts on children’s reading skills. We use a risk-resilience model as the framework for this
project, which recognizes children have varying levels of risk factors that make them more or less likely to be
affected by COVID-19 related disruptions to their sources of resiliency. We will capitalize on an existing active
national twin project, the National Project on Achievement in Twins (NatPAT). NatPAT has already enrolled a
cohort of 1801 pairs of twins (and growing) and has been tracking them as they progress through elementary
school, collecting their reading progress monitoring data three times a year. We will continue to enroll twins
into NatPAT using our successful and established recruitment procedures, and collect their ongoing reading
data. In addition, every summer for all five years of the grant, any twin family with children in grades
kindergarten to 6 will be mailed a survey packet to their homes. This packet will contain a parent and child
survey with questionnaires related to their experiences over the last school year related to COVID-19 impacts,
specifically their social interactions, health and economic status and changes, and their experiences with digital
technology. Using methods that allow us to understand causal relations, we are uniquely situated to address
the overall goal of the proposed research through three specific aims (SA). First, we will quantify the short and
long-term effects that losing social resources due to COVID-19 has on reading skills (SA1). Second, we will
quantify the short and long-term effects of COVID-19 related health and economic stressors on reading skills
(SA2). Finally, we will quantify the short and long-term effects of the digital-divide on reading skills during
COVID-19 (SA3).

Public health relevance
PROJECT NARRATIVE This project will uncover the mechanisms through which COVID-19 has and will have short-term and long-term impacts on children’s reading skills. We use a risk-resilience model as the framework for this project, which recognizes children have varying levels of risk factors that make them more or less likely to be affected by COVID-19 related disruptions to their sources of resiliency. This project will help us understand how the COVID-19 pandemic is affecting children, as well as add to our general knowledge about how trauma affects children.